CHIME Research Education Component (REC)

Project Summary for the RCMAR CHIME Research Education Component
The mission of the Research Education Component (REC) is to develop leaders in minority aging research, by
supporting our Center theme of “Developing, Adapting and Evaluating Interventions to Improve the Health of
Minority Elders,” which incorporates elements of two of the RFA areas of scientific focus: (i) research aimed at
understanding and modifying behaviors associated with health outcomes in later life, and (ii) research on
factors that affect population aging and its consequences. The four Specific Aims of the REC are to: 1) Identify,
recruit and encourage a cadre of underrepresented faculty and fellows with demonstrated research potential
and interest in diversity aging research to apply as RCMAR scientists, 2) Select with input from the External
Advisors at least 3 outstanding RCMAR Scientists to receive 1-year pilot studies (with matching UCLA CTSI
funds) at a level of up to $45,000 per pilot award, 3) Provide intensive individual mentorship and a broad array
of educational and infrastructural resources to enable RCMAR Scientists to successfully complete, present and
publish their research and ultimately obtain independent research funding, and 4) Closely monitor the progress
of RCMAR Scientists using a standardized program of progress reports, mentorship committee meetings and
progress review by the CHIME Executive Committee (EC). For this renewal application, the REC has identified
3 RCMAR Scientists to lead pilot projects: 1) Lourdes R. Guerrero, EdD, MSW, who aims to measure the
impact of the Aging Mastery Program®, designed to support older adults as they take steps to improve their
lives and stay engaged in their communities, 2) Joseph A. Ladapo, MD, PhD, who aims to conduct a
randomized controlled trial to compare whether a social network text message intervention versus private
feedback leads to better adherence to evidence-based drug therapy for older minority patients, and 3) Kimberly
Narain, MD, PhD, who aims to study whether enhanced care coordination for older adults who are covered by
Medicare and Medicaid (dual eligible) leads to fewer hospitalizations and emergency room visits versus dual
eligible older adults with standard coverage. The first two research pilots address focus area (i), while the third
pilot addresses focus area (ii).